Mechanisms of novel host factors in alphavirus infection

Alphaviruses include important and emerging human pathogens such as encephalitic viruses and the
arthritogenic chikungunya virus. In spite of their importance, there are currently no licensed antiviral therapies
or vaccines. New approaches and information are needed to develop antiviral strategies.
Alphaviruses are small enveloped viruses with highly ordered structures. The nucleocapsid core
contains the plus-sense RNA genome packaged within a capsid protein shell. The core is surrounded by the
virus envelope, which contains an organized array of the E2 and E1 transmembrane proteins. The structure
and function of the virus and viral proteins have been extensively characterized. However, there is
comparatively little information on the role of host proteins in the virus life cycle, in particular for steps such as
the uncoating of the incoming viral RNA during entry, the assembly and transport of the nascent nucleocapsid,
and the budding of virus particles from the plasma membrane. We used an innovative approach to identify host
proteins that specifically associate with the capsid/nucleocapsid during infection. The approach is based on
biotinylation of the capsid protein in alphavirus-infected cells, chemical crosslinking, specific capsid protein
retrieval under denaturing conditions, release of crosslinked cellular proteins, and identification of significant
host protein association by mass spectrometry. These candidate host factors were evaluated by siRNA
depletion for effects on infection by two different alphaviruses. Based on extensive preliminary results, we
propose to characterize 4 host proteins for their previously unidentified pro-viral roles in alphavirus infection.
The specific aims are:
1. Define the role of novel host proteins in the alphavirus exit pathway. Depletion of two host
proteins inhibited alphavirus spread but did not affect primary infection or envelope protein expression at the
cell surface. DARS is the cytoplasmic aspartyl tRNA synthetase, and part of the dynamic multi-tRNA
synthetase complex (MSC). Its depletion phenotype suggests that DARS plays a role in steps other than
protein synthesis, perhaps involving the MSC. YWHAB is a member of the family of 14-3-3 adaptor proteins,
which can regulate protein-protein interactions and protein modifications. We will use our established panel of
assays to define the role of DARS and YWHAB in the virus exit pathway.
2. Define the role of novel host proteins in early steps in the alphavirus life cycle. Depletion of
two host proteins inhibited both virus spread and primary infection, but did not inhibit viral RNA replication. We
will perform mechanistic studies to define the differential roles of Rab1B and b spectrin in virus infection.
The results of these studies will provide fundamental information on host proteins involved in the
alphavirus life cycle, and potential new targets for antiviral strategies.

Public health relevance
Narrative Alphaviruses include established and emerging human pathogens that cause serious diseases and are potential biodefense threats, and for which there are no antiviral therapies. This project aims to define the role and mechanisms of newly identified host cell proteins in the alphavirus infection cycle. The results will provide fundamental information on alphavirus-host interactions and inform new antiviral strategies.